Glycolipid Translocation in Mycobacteria

Project Summary:
Bacterial cell surface glycolipids function in critical roles in the adaption of bacteria to their environment and
pathogenesis. Owing to their extracellular location and functional importance, considerable work has been
devoted to delineating bacterial glycolipid biogenesis (biosynthesis and transport). While significant advances
have been made in the identification of transporters in particular in Gram-negative bacteria, these processes
remain wholly opaque in the specialized Gram-positive organisms belonging to the order Actinomycetales .
Actinomycetales of the mycolata group (i.e., mycolic acid containing species), which contain notorious human
pathogens, including Mycobacterium tuberculosis and Corynebacterium diphtheriae, are characterized by a cell
envelope of unique composition and structure suggestive of highly specialized biosynthetic and translocation
machineries. Some of the most studied glycans in the cell envelope of mycolata species for the important roles
they play in physiology and pathogenesis are mannosylated glycolipids and lipoglycans known as
phosphatidylinositol mannosides (PIMs) and their multi-glycosylated counterparts, lipomannan (LM) and
lipoarabinomannan (LAM). While many enzymes in the PIM, LM, and LAM biosynthetic pathway have been
discovered, the transporter(s) responsible for translocation of PIM intermediates across the plasma membrane,
and of PIM, LM and LAM to the outer membrane (mycomembrane) and cell surface are not known. This
application proposes to gain the first insights into the molecular mechanisms governing PIM, LM and LAM
translocation across the different layers of the cell envelope of mycolata group bacteria. A current obstacle to
the discovery of these elusive transporters is the lack of biochemical tools to topologically and specifically label
PIMs. To address this deficiency, I have devised a multidisciplinary approach encompassing chemical biology,
glycobiology, genetics and protein-protein interactions. First, I will develop a set of tools that can directly label
PIMs that have undergone translocation across the plasma membrane [Aim 1]. These tools, in combination with
traditional genetic, biochemical and protein-protein interaction approaches, and a newly developed cell sorting-
based assay to screen of a transposon mutant library will enable the identification of specific PIM and LAM
transporters [Aim 2].
Success in these studies would advance long-standing questions regarding (glyco)lipid transport in
Actinomycetes, and PIM, LM and LAM biogenesis in mycobacteria in particular. The new knowledge generated
therein and translocation assays arising from Aim 1 may further find applications in the development of innovative
therapeutic strategies to treat Corynebacterineae infections.

Public health relevance
Project Narrative: The atypical composition and organization of the shared mycobacterial cell envelope is vital for subversion of the immune system and a significant barrier to the penetration of drugs. While the processes governing (lipo)polysaccharide and (glyco)lipid export have been an area of active research in Gram-negative bacteria for over two decades, virtually nothing is known of the transport mechanisms used by mycobacteria and closely related Actinomycetes to build their unique cell envelope structures. This application proposes to fill a gap in our understanding of this critical aspect of the physiology of Actinomycetes.